Dye-loaded Nanoparticle Platform for Rapid and Sensitive Vivarium Pathogen Detection

Project Summary
This proposal develops key aspects of an ultrasensitive pathogen detection system for rodent animal health
surveillance and is in response to the NIH FOA PAR-21-225 to develop novel tools and devices for animal
research facilities and to support the care of animal models. The goal of the project is to develop a microfluidic
device for rapid and inexpensive pathogen detection directly from an animal or from soiled bedding. The device
will be used cage-side and will complement current rodent health monitoring programs which are designed to
monitor rooms or cage racks quarterly. Use of the device will encourage rapid outbreak mitigation and resolution
as well as confirm health status for animal importation. The advantages of the platform will be specificity,
simplicity, speed, and sensitivity in a “3Rs” consistent approach.
The specificity of the detection system relies on DNA hybridization of a synthetic oligonucleotide designed
specifically for the pathogen of interest with DNA captured from infectious agents directly from the rodent or from
bedding samples. The detection step will be rapid since the DNA hybridization will not rely on cyclic amplification
of the DNA but instead will shift the sensitivity requirements to release of dye from mesoporous silica
nanoparticles using pH-dependent dye release. In this Phase I proposal, the key aspects of the platform will be
optimized and tested for feasibility in 4 Aims. First, the pathogen DNA preparation protocol will be established
using a bacterial and viral DNA source, and the limit of pathogen detection quantified for DNA collection. Second,
the synthetic oligonucleotide that serves in pathogen detection will be optimized and bound to magnetic
nanoparticles. Third, internal pores and external surfaces of mesoporous silica nanoparticles (mSNPs) will be
differentially labelled so that the internal surfaces are saturated with reversibly bound dye molecules while the
external surfaces are coated with DNA that will hybridize with the pathogen specific detection oligonucleotide.
Lastly, proof of feasibility of the platform will be tested by combining the pathogen detection and ultrasensitive
pH-responsive dye release aspects. The innovation of this platform is in the use of DNA secondary structure to
provide pathogen specificity, the use of mSNPs designed specifically for saturated dye loading with pH-sensitive
dye release, and the use of DNA hybridization to physically bind the specificity and sensitivity features together,
allowing enrichment of the detection complexes with the use of magnetic nanoparticles.

Public health relevance
Project Narrative Rodents are used extensively for biomedical research and are essential for study of physiology, disease, and therapeutics. The basic health and wellbeing of rodent models used in research is of the utmost concern because animals infected with pathogens will not have the same clinical or experimental outcomes as healthy animals, affecting the rigor of scientific outcomes. This proposal develops an ultrasensitive pathogen detection platform for cage-side health surveillance to encourage rapid outbreak mitigation and resolution as well as health status confirmation.